CD8 T Cell Response to Murine Cytomegalovirus

DESCRIPTION (provided by applicant): Cytomegalovirus (CMV) infection is characterized by enormous effector/memory T cell responses that are maintained at high levels for life- a phenomenon known as memory inflation. We have reported that inflationary memory cells are in fact short lived effector cells continuously differentiating from true memory cells generated early during infection. The true memory cells are not readily transferred from the spleen of an infected host to an infected recipient, and we suggest that they reside in a stromal niche. We have also shown that a single cycle CMV which is unable to spread beyond the cells it infects upon first entering the body drives surprisingly robust memory inflation. These two findings define the paradox that we seek to unravel in this project: how can a tiny number of infected cells present antigen to keep the immune system constantly activated without being subject to immune eradication? We first ask whether the information about viral presence is transmitted to T cells through direct or cross presentation of viral antigen. This will be accomplished by generating a virus expressing Kb in order to limit antigen presentation to directly infected cells. We will next use an iterative process of organ digestion, cell sorting and bioassays to identify the cells that carry the viral genome and the cells that present antigen to T cells. As an alternative approach, we will generate virus which can be used to infect cre mice to limit antigen expression to particular tissues or cell types. Finally, we will characterize the latently infected cells with respect to their immunological phenotype, their viral gene expression, and their sufficiency for driving memory inflation upon co-adoptive transfer with memory CD8 and CD4 T cells. Understanding the viral program that drives memory inflation will enable us to intelligently engineer CMV-vectors as vaccines to generate potent immune responses. It will also help us to understand CMV's role in certain chronic diseases, and its putative association with immunosenescence. PUBLIC HEALTH RELEVANCE: Cytomegalovirus is a ubiquitous human virus that excites an extremely large immune response from the infected host. This enormous immune response can be harmful, contributing to immunosenescence in the elderly, or helpful, when CMV is used as a vaccine vector. It is not known why the immune response is so large, and the mystery was heightened by our discovery that even a non-infectious CMV vaccine drives an enormous response. The goal of this project is to understand exactly how CMV excites this unprecedented response. Using the non-infectious vaccine, we will find the cells that drive the response and determine how they interact with the immune system to drive the response. This knowledge will be exploited directly in our other work to develop a CMV-based cancer vaccine.

Public health relevance
Cytomegalovirus is a ubiquitous human virus that excites an extremely large immune response from the infected host. This enormous immune response can be harmful, contributing to immunosenescence in the elderly, or helpful, when CMV is used as a vaccine vector. It is not known why the immune response is so large, and the mystery was heightened by our discovery that even a non-infectious CMV vaccine drives an enormous response. The goal of this project is to understand exactly how CMV excites this unprecedented response. Using the non-infectious vaccine, we will find the cells that drive the response and determine how they interact with the immune system to drive the response. This knowledge will be exploited directly in our other work to develop a CMV-based cancer vaccine.